TB/MDR-TB Research training and Capacity Strengthening for LMIC in Southeast Asia Phase II: Promotion of Diversity, Equity and Inclusion (DEI)

Project Summary/Abstract
Tuberculosis (TB) is still an overwhelming infectious in Southeast Asia, especially in remote geographical
areas and among the minority ethnic group due to socio-economic constraints. Based on " Administrative
Supplements to Fogarty International Center's (FIC) Training Grants to Promote Diversity, Equity, and Inclusion
(DEI) diversity (NOT-TW-23-006)", there is a need to provide opportunity for under-represented group to
join research career. Researchers who are from this disadvantage group are few due to inequity in
opportunity in higher education in LMICs (Low- and Middle-income Countries). The current proposal is
prepared to serve this purpose.
Our parental project " TB/MDR-TB Research training and Capacity Strengthening for LMIC in Southeast Asia "
D43TW009522 is based in Southern Thailand and includes provinces of Sumatra Island of Indonesia.
Both areas have minority ethnic groups with poor access to scientific research education. Given that our
training program has successful records in training new TB scientists to serve the areas, our program is
in good position to expand the opportunity to these under-represented group by provide them with
training on TB research.
Here we have two target groups in these two countries.
The first group is a small group of Muslim women who are faculty members of Faculty of Science and
Technology, Pattani Campus of PSU. They hold PhD degrees and teach statistics but have only little
exposure to the modern sciences of tuberculosis, especially Bioinformatics and other bio-medical data
sciences. The specific aims for training of this group include enhancing the trainees' understanding in
Bioinformatics and other related bio-medical data sciences to enable them to participate in ongoing TB
research activities. Training of these two scientists from the under-representative group will lead to
more diversification of TB scientists for Thailand, who work in the under-privileged region of the
country. The training sites include Faculty of Medicine of PSU, Hatyai Campus and Faculty of Science and
Faculty of Medicine, Siriraj Hospital of Mahidol University, Bangkok. The trainees will spend 4 weeks at
each site followed by research activities at their home institution.
The second target research trainees are young university bachelor graduates from Sumatra Indonesia
who are from communities of minority ethnic groups. They are working with PSU alumni in Indonesia
who are leading TB laboratory researchers in Universitas Sumatera Utara (USU) of North Sumatra and
Discipline of Statistics of Universitas Syiah Kuala (SKU) of Aceh Province of Indonesia. The training will be
arranged at each university followed by involvement of the trainees on local TB research activities.
At the end of the year, all trainees will have debriefing and summary activities at the Department of
Epidemiology, PSU, which is the main training site of the current D43 grant) for one week.

Public health relevance
Project Narrative Our parental project "TB/MDR-TB Research training and Capacity Strengthening for LMIC in Southeast Asia", D43TW009522 has well established training collaboration between Prince of Songkla University and Mahidol University and Methodist Hospital, Houston Texas in Master, and PhD levels for Myanmar, Thailand, and Indonesia. In this Administrative Supplement Grant "Notice of Special Interest (NOSI) for Administrative Supplements to Fogarty International Center's (FIC) Training Grants to Promote Diversity, Equity, and Inclusion (DEI)", we expand training opportunity to the group of young scientists who come from groups under-represented in science, especially TB research and from the community with high TB burden. This effort will increase the livelihood of the scientific community and lead to improvement of TB research in the needy but neglected areas.